Exploratory study of pesticide use and coccidioidomycosis

SUMMARY
In 2023, California suffered the greatest number of cases of coccidioidomycosis (Valley fever) in its
history. Climate change–in particular cycles of unusually wet and dry years–are suspected to be responsible
for both local increases and the widening of this endemic fungus’ geographic distribution. Although outdoor
laborers are at higher risk of coccidioidomycosis that other individuals, agricultural soil is less likely than non-
agricultural soil to harbor the pathogen, raising the possibility that pesticides alter environmental colonization.
Fungicides could directly kill Coccidioides, resulting in reduced colonization of soil where pesticides are
applied; loss of the pathogen would potentially lead to fewer local cases of disease. Alternatively, fallow land,
that had previously been treated with pesticides may be permissive of recolonization with Coccidioides
endospores through the pesticides’ disruption of competing microbial communities; this could lead to more
cases of disease after the fallowing.
We propose an exploratory study to evaluate whether pesticides are geographically and temporally
linked to human coccidioidomycosis cases or environmental Coccidioides. We hypothesize that environmental
pesticides, particularly fungicides and rodenticides, alter local coccidioidomycosis risk and seasonality by
perturbing pathogen density within environmental reservoirs. We will take advantage of three data sets
including: detailed, aggregated, publicly available pesticide use information to identify monthly applications of
pesticides at the level of both the census tract and the individual residence from 2000 to 2023; monthly data
previously obtained from the California Department of Public Health over the same time period on incident
coccidioidomycosis cases; and data from our group on Coccidioides in 1500-2000 soil samples collected from
the Central Valley. We will then use a variety of sophisticated statistical methods to address two aims: Aim 1)
Evaluate environmental pesticide use, particularly fungicides and rodenticides, as a risk factor for
coccidiomycosis in California over a period of 20 years; and Aim 2) Evaluate environmental pesticide use,
particularly fungicides and rodenticides, as a risk factor for Coccidioides detection in soil samples. Analyses will
adjust for climatic factors and for specifics of land use, and will assess pesticides in general as well as
rodenticides and fungicides.
Understanding whether and how soil applications of antimicrobial agents like pesticides and fungicides
affect coccidiomycosis incidence and Coccidioides distribution will provide insights into primary prevention of
this infection in humans and animals. Future studies that may stem from this work include direct assessments
of pesticide concentrations in soils with and without Coccidioides, as well as veterinary surveillance of animals
in pesticide exposed areas.

Public health relevance
PROJECT NARRATIVE Coccidioidomycosis, a potentially life-threatening infection more colloquially known as Valley fever, is spreading throughout the western United States in humans and animals, possibly due to climate change-induced fluctuations in rainfall and temperature. Coccidioides lives in soil, particularly in the agricultural heartland of California—the Central Valley. In this exploratory study, we will assess whether pesticides, particularly those that kill fungi and rodents, influence the distribution of Coccidioides and whether the use of these agents can inform future preventive measures against Valley fever.